ACTG 323--FLUCONAZOLE AS CHRONIC SUPPRESSIVE THERAPY VS EPISODIC THERAPY

To compare 2 long-term management strategies (chronic suppressive vs. episodic therapy) for oropharyngeal candidiasis using Fluconazole.